Developing an intervention to improve follow-up of abnormal fecal immunochemical test results in a safety-net population using a mixed methods approach

Project Summary
Rachel Issaka, MD, MAS’ long-term career goal is to become an independent researcher and leader in
developing, implementing, and evaluating interventions to reduce colorectal cancer (CRC) mortality in medically
underserved populations. She has identified improving follow-up of abnormal fecal immunochemical test (FIT)
results as a critical issue to address to achieve this goal. This proposal describes a 5-year comprehensive
program of training and mentored research for an academic career in health outcomes research. The research
agenda is in line with one of NCI’s five scientific goals: to improve cancer prevention and control. In this goal,
advancing health care equity in medically underserved populations is an area of special focus. While Dr. Issaka
has a strong background in clinical gastroenterology and safety-net systems-level research, this K08 will provide
key training in advanced multilevel statistical modeling, qualitative research methods, mixed methods research,
and intervention development. FIT is promoted over colonoscopy for CRC screening in federally qualified health
centers (FQHCs) and safety-net health systems due to patient preference and limited colonoscopy resources.
For FIT-based screening to effectively reduce CRC-mortality, abnormal results must be followed by a diagnostic
colonoscopy. However, FQHCs and safety-net health systems do not consistently track follow-up of abnormal
FIT results and failure to complete a diagnostic colonoscopy increases CRC-mortality by up to 3-fold. Research
suggests approximately 50% of safety-net patients with an abnormal FIT do not complete a diagnostic
colonoscopy within 1 year of their result. This highlights the importance of identifying and describing the barriers
to diagnostic colonoscopy completion after abnormal FIT results in order to develop effective interventions. The
study’s specific aims are: (1) using mixed methods, identify the potentially modifiable patient, provider, and clinic-
level barriers to diagnostic colonoscopy in patients with abnormal FIT results in a large safety-net health system;
and (2) based upon intervention targets identified in Aim 1, develop a pilot intervention to improve diagnostic
colonoscopy completion in a safety-net population with abnormal FIT results. Dr. Issaka’s mentorship team
including world-renowned gastroenterologists, health services researchers, qualitative and mixed methods
experts and implementation scientists will provide experiential guidance to complement her didactic training.
These factors in addition to the supportive research environments at the Fred Hutchinson Cancer Research
Center and the University of Washington, will enable her to achieve the proposed project aims. Upon completion
of the proposed research and training, Dr. Issaka will submit a competitive R-level grant application to test the
pilot intervention in a randomized trial and will possess the skills and experience to make sustained and impactful
contributions to reduce CRC-mortality through evidence-based interventions that improve follow-up of abnormal
FIT results.

Public health relevance
Project Narrative Failure to complete a diagnostic colonoscopy after an abnormal fecal immunochemical test (FIT) increases colorectal cancer (CRC)-mortality by up to 3-fold. Yet, in medically underserved settings where FIT is the cornerstone of CRC screening, approximately 50% of patients with an abnormal FIT do not complete a diagnostic colonoscopy within 1 year of their result. Using a mixed methods approach, the proposed project will address this persistent challenge in CRC prevention and control by developing an evidence-based intervention to improve follow-up of abnormal FIT results in a large safety-net health system.